SCIENTIFIC JOURNAL EDITING

M. L. Gross serves as editor of the Journal of the American Society for Mass Spectrometry. Joyce Neff, resource secretary and staff assistant, also serves as editorial assistant. In 1997-98, the journal continued an on-line or electronic version, the first among mass spectrometry journals. Gross also serves on the editorial board of Mass Spectrometry Reviews, and International Journal of Mass Spectrometry and Ion Processes.